Core B: Animal Models and Pathology

SUMMARY The Animal Models and Pathology Core is established to provide essential animal and pathology resource components that comprehensively support research Projects utilizing animal models. The Specific Aims of this Core are: Specific Aim 1 - To maintain quality controlled breeding colonies for various mouse strains; Specific Aim 2 - To develop novel strains of transgenic mice and maintain breeding colonies of mice that will be specifically utilized by individual Projects in the Program; Specific Aim 3 - To generate mouse embryonic fibroblasts (MEFs) from various mice strains proposed in individual projects; Specific Aim 4 - To provide animal pathology services for in vivo cancer models; and Specific Aim 5 - To provide services for tumor tissue staining and characterization by IHC and TMA.

Public health relevance
NARRATIVE The central objective of the Animal Models and Pathology Core is to provide the PPG investigators with the knowledge, resources, and ability to utilize animal models, pathological examination, and analyses in the execution of their research projects and their advancement to preclinical studies. The Core is an integral part of the research program with regard to examination of lipid metabolism and signaling mechanisms involved in the pathogenesis and treatment of solid tumors.